REMYELINATION AND AXON INTEGRITY IN CHRONIC DEMYELINATION

In multiple sclerosis (MS) lesions, remyelination typically fails with recurring or chronic myelin damage. Our preliminary studies show the advantages of a reproducible model of chronic cuprizone demyelination for focusing on this compromised repair response. Importantly, our preliminary data in FGF2-I- mice demonstrates that it is possible to overcome chronic lesion effects on endogenous oligodendrocyte lineage cells to increase remyelination. The FGF2-I- mice do not develop corpus callosum atrophy with chronic demyelination, which indicates a potential for remyelination to attenuate axon damage. Examining the compromised repair after chronic demyelination in wild type mice and the improved response in FGF2-I- mice may reveal potential strategies to enhance recovery in chronic demyelinating diseases. We have shown that the predominant cellular response affected by removal of endogenous FGF2 in vivo during development and remyelination is inhibition of OP differentiation (Murtie et al., 2005a, b). Our current hypothesis is that in chronically demyelinated lesions, inhibitors of OPdifferentiation impair remyelination and prolong pathological reactions in denuded axons. The proposed Aims each address a critical issue to unravel the cellular and molecular interactions mediating OP differentiation effects on remyelination and axon integrity after chronic demyelination. Aim 1 will characterize the structural effects of FGF2 absence on myelin and axon pathology. Specifically, these studies will correlate myelination status with axonal reactions, as identified by atrophy, neurofilament dephosphorylation, and sodium channel diffusion beyond nodal boundaries. The FGF2 effect on recovery from chonic remyelination can be better exploited to therapeutic advantage in the future once the partners (i.e. target cell type and FGF receptor type) in this response are identified in the studies of Aim 2. Aim 3 will test whether improved recovery from chronic demyelination is a generalizable effect from removing inhibition of OP differentiation or, alternatively, is an effect specific to the FGF2 pathway. These studies should test the role of inhibitors of OP differentiation in promoting remyelination and preventing axon damage. Furthermore, specific components of the relevant signaling pathways will be identified. These findings can then direct repair strategies that may be a valuable complement to strategies that abrogate myelin damage in MS and other demyelinating diseases.